Structural Mechanisms of Ribosome Assembly

Protein translation by the ribosome is essential for cellular life but not much is known about the molecular mechanisms governing how ribosomes are made. Ribosome biogenesis is a major consumer of cellular energy and an incredibly complex pathway involving more than 300 trans-acting factors that is regulated by well-known tumor suppressors including p53 and Rb as well as protoncogenes such as cMyc and TOR, and is emerging in the field as a new target for cancer therapy. Currently we are taking a structure/function approach to decipher the roles of several protein complexes that are essential for ribosome assembly and cell viability. Through a combination of x-ray crystallography, yeast genetics, and immunofluorescence we have been able to reveal how a well conserved pre-rRNA processing complex is released from pre-ribosome particles in the nucleolus in both yeast and mammalian cells.